CORE A1: MENTORING CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The primary goal of this COBRE proposal is to increase the number of NIH-supported biomedical researchers in the state of South Carolina, particularly at Clemson University (CU). For this purpose, CU's unique strengths in biomaterials and tissue engineering will be complemented by expertise in medicine and developmental biology at the Medical University of South Carolina (MUSC) and the University of South Carolina (USC) to establish a Center of Biomaterials for Tissue Regeneration (CBTR) at CU. To accomplish the center's goal, an outstanding cadre of mentors mentor junior investigators toward independence as NIH-supported investigators. The center's tissue-regeneration theme simultaneously fits South Carolina's strength in regenerative medicine while addressing a significant cause of mortality and morbidity worldwide: End-stage organ failure and tissue loss create healthcare costs of nearly $400 billion annually in the US alone. Research in tissue regeneration offers the possibility of relief for these human and economic costs through restoration of functional tissues. The scientific focus of this center is regulation of tissue regeneration through cell biomaterials interactions. Five projects from junior investigators have been rigorously selected to fit this theme. These projects are 1) Stem cell-myocyte electrical coupling via a laser-patterned cell bridge;2) Biomaterials for guided neural regeneration;3) Understanding and Controlling Tissue-specific Vascular Patterning;4) Mechanically guided urological tissue regeneration in vitro;and 5) Enabling Technology for Brain Tissue Regeneration after Stroke. Two pilot projects are also supported from cost share money. These target investigators are paired with mentors who are established, NIH-supported researchers with excellent track records in mentoring and with surgeons who will keep projects clinically relevant. The projects are supported by a well-organized infrastructure and three state-of-the-art core facilities (Materials Synthesis, Characterization and Testing, Histology and Imaging, and Cell and Molecular Engineering). Our nationally recognized External Advisory Committee members will critically evaluate the center's progress. This COBRE center will significantly augment collaborative efforts in South Carolina to recruit, train, and retain a critical mass of investigators with cross-disciplinary skills to collaborate effectively in the research area of regenerative medicine.